Investigating the Role of Diet and ACSS2 in Metabolic and Epigenetic Regulation of Colorectal Cancer

PROJECT SUMMARY/ABSTRACT
Colorectal cancer (CRC) is a leading cause of cancer mortality and is significantly affected by multifactorial
influences including host genetic and epigenetic factors, diet, and microbial composition. One of the most
intriguing interventions for mitigating cancer risk and progression is modifying dietary behavior, a powerful
approach that has been increasingly investigated. While many studies focus on individual dietary components,
it is unclear how distinct metabolic inputs from the dietary milieu integrate to influence cancer
progression. Two major nutrients that have been extensively linked to CRC are fructose and fiber.
Fructose is highly enriched in Western diets and promotes intestinal tumorigenesis by accelerating de novo
lipogenesis (DNL) and glycolysis. Fiber is metabolized by the gut microbiota to produce short-chain fatty acids
(SCFAs), which exert anticarcinogenic activity. Fructose and acetate, the most abundant SCFA, converge
at a common downstream metabolite, acetyl-CoA, which can be used for DNL or histone modification, making
it a central metabolite critical to metabolism and epigenetic regulation. This makes fructose and acetate prime
candidates for evaluating crosstalk between multiple dietary inputs in CRC. ACSS2 is the enzyme responsible
for converting acetate to acetyl-CoA and is a gene target of several transcription factors which are
activated in response to fructose consumption. Thus, ACSS2 is important due to its position at the nexus of
catabolic and anabolic metabolism. A key focus of this proposal is on the metabolic and epigenetic effects of
dietary fiber and fructose and the role of ACSS2 in mediating these effects. My preliminary data suggest that
loss of ACSS2 expression is associated with greater CRC tumor grade and progression. This is potentially due
to the downregulation of cell differentiation genes and upregulation of genes relevant to CRC tumor metastasis,
such as epithelial-mesenchymal transition. Using a mouse model, we found that manipulating dietary fiber and
fructose led to changes to host metabolism in opposing directions, highlighting the need for understanding the
integrated effects of these particular nutrients in the cancer context. I hypothesize that fructose manipulates
acetyl-CoA pool utilization to prioritize biosynthetic pathways that are advantageous for tumor growth
and that acetate exerts epigenetic effects on colonic differentiation gene targets, which are mediated by
ACSS2-directed histone acetylation. Aim 1 will determine how acetate and fructose interact to affect CRC
growth and acetyl-CoA metabolism through in vitro organoid and cell culture models and in vivo genetic mouse
models. Aim 2 will identify the mechanism by which acetate, fructose, and ACSS2 regulate CRC epigenetic
modifications and differentiation status through histone proteomics, RNA sequencing, and chromatin
immunoprecipitation sequencing. This project will provide novel insights into the combinatorial effects of fiber
and fructose and the influence of host gene-diet interactions on susceptibility to dietary impacts on CRC. Our
work has significant implications for dietary interventions that can profoundly impact cancer patient care.

Public health relevance
PROJECT NARRATIVE Studies of how distinct dietary inputs integrate to affect colorectal cancer metabolism and epigenetic regulation are limited. This project will contribute to our understanding of how metabolic pathways regulate the differentiation and function of CRC, as well as how manipulation of host genetics can augment or limit the efficacy of dietary interventions. Determining the interaction between dietary inputs in the context of host genetics has the potential to identify novel mechanisms to inform dietary interventions to prevent and combat CRC.